BRAIN GLUCOSE UTILIZATION

In normal man, plasma glucose and insulin concentration are known to remain steady throughout the night. Yet, rates of systemic glucose production and utilization decrease in parallel by approximately 20% in the first hours of sleep. We intend to test the hypothesis that a declining rate of whole brain glucose utilization is responsible for the observed fall in systemic glucose utilization during sleep.